Roybal Center for Behavioral Interventions in Aging

Abstract
The Management and Administrative Core fosters collaborations between behavioral and
clinical researchers that advance science that employs behavioral economics to improve
delivery of medical care. These collaborations are guided and directed by the Management and
Administrative Core. Consistent with the NIH Stage Model for behavioral research, the Center
will evaluate the relevance, and apply appropriately, fundamental social and cognitive principles
to each stage of research. The Pilot Core for the Roybal Center for Behavioral Interventions in
Aging will develop and test interventions based on insights from behavioral science to promote
healthy aging. The specific aims of the Center are to: (1) Strengthen the ability of clinicians
everywhere to choose or recommend the safest and most effective treatments for their patients
through the use of insights from behavioral science developed at the Center; (2) Provide
stewardship and support to the Center’s advisory board; (3) Oversee pilot proposal
development, selection, and progress monitoring; and (4) Promote widespread dissemination
and adoption of successful interventions. The Management and Administrative Core supports
the NIH Five Stage Model for behavioral interventions in directing research and the pathways of
pilot projects year-to-year. As part of its responsibilities, the Management and Administrative
Core will coordinate travel to Center meetings annually, held at the NIH in Bethesda, MD, or at
another site agreed to by the Principal Investigators and the National Institute on Aging. The
Management and Administrative Core also assesses impact of potential pilot studies through
simulation results using the Future Elderly Model. This to ensure the highest priority behavioral
interventions are chosen. During the course of the award, the Management and Administrative
Core’s key contribution is its role in fostering close collaborations between behavioral scientists
and clinical researchers to address some of the Nation’s most pressing population health
concerns that are driven by overuse of medical services and underuse of comparatively
effective services.

Public health relevance
Narrative The Management and Administrative Core fosters collaborations between behavioral and clinical researchers that advance science that employs behavioral economics to improve delivery of medical care. The Core supports research pilots and other Center activities. Selection of additional pilots in out-years are informed by health policy simulation impact models conducted at the Management and Administrative Core.